Control of thalamic circuits by a higher-order cortical area

Project Summary/Abstract
This project will investigate how a higher-order cortical area modulates thalamic activity to shape sensory
perception. Almost all sensory information passes through the thalamus en route to the cortex, and traditionally
the thalamus has been considered a simple relay. However, the neocortex also provides robust projections to
the thalamus, with descending corticothalamic (CT) axons outnumbering ascending thalamocortical (TC) axons
by about 10:1. The anatomy alone implies that thalamic functions are complex, and that the cortex likely exerts
a substantial influence on the thalamus and, through this, on its own inputs.
CT communication plays a role in conditions such as epilepsy, schizophrenia, and attention deficit disorders. A
thorough understanding of CT function has remained elusive, and most studies of CT pathways have explored
unimodal primary sensory areas or the prefrontal cortex. Similar motifs in the anatomy and physiology of these
circuits have emerged, raising the questions: Does every cortical area have a similar pattern of feedback to the
thalamus? How are diverse CT pathways relevant to vastly different types of behavior?
The parahippocampal cortex (called the postrhinal cortex, POR, in rodents), is a polymodal association area
and the principal source of visual information to the hippocampus. The POR is heavily interconnected with the
pulvinar nucleus of the thalamus (also known as the lateral posterior nucleus in rodents). POR and pulvinar
have both been implicated in networks mediating visual attention, yet almost nothing is known about the
structure and function of CT pathways from POR to pulvinar.
The central goal of this proposal is to determine how top-down projections from cortical area POR influence the
functions of the thalamic pulvinar nucleus at the level of cellular, synaptic, and circuit mechanisms. Aim 1 is a
deeper understanding of the anatomy of the CT projection, including their origins in POR and their projection
patterns in pulvinar and neighboring inhibitory circuits. For this I will utilize viral transduction strategies,
immunohistochemistry, and imaging. Aim 2 is to characterize the intrinsic and synaptic physiological properties
of the POR-to-pulvinar pathway using in vitro whole-cell recordings, optogenetics, and Cre-expressing mouse
lines to target projections in a cell- and layer-dependent fashion. Aim 3 is to explore the functions of this
pathway in awake animals by recording single-unit and local field potential activity in the POR and pulvinar
during visual stimulation and optogenetic manipulation of the CT pathway.
The applicant will receive first-rate training from two Co-Sponsors with complementary expertise in cortico-
thalamic and corticohippocampal circuits, and in a range of techniques for cellular neurophysiology, anatomy,
systems, and behavioral neuroscience. The applicant’s research will reveal new cellular, circuit, and functional
features of corticothalamic control exerted by higher-order cortical area on the visual thalamus.

Public health relevance
Project Narrative This project will assess how the neocortex controls activity and sensory processing in the thalamus. The neocortex, thalamus, and their connections comprise the vast majority of the human brain, and their bidirectional interactions are thought to be critical for sensation, perception, control of movement, and cognition. Communication problems between the neocortex and thalamus are common features of many neurological and psychiatric diseases, so the results of my research will contribute to a base of knowledge that may lead to improved treatment strategies.